Novel translational strategies to combat group B streptococcus infections

Group B streptococcus (GBS) is a major human pathogen that infects diverse anatomic sites and cause wide
spectrum of disease manifestations. GBS infections are the leading cause of stillbirths, preterm births and
neonatal mortality worldwide. The existing control measures to treat or prevent human GBS infections are
significantly challenged by the lack of a human vaccine as well as the rise in antibiotic resistance among GBS
strains. Thus, novel translational approaches are urgently required to treat GBS infections. We discovered that
a human probiotic produces a previously unknown antibiotic, salivabactin, that is potent in inhibiting the growth
of pathogenic streptococci in vitro and in vivo. We also found that the probiotic bacteria produce salivabactin only
transiently, which contributes to its reduced probiotic efficacy. To overcome this, we engineered the probiotic to
augment salivabactin production and showed its improved prophylactic efficacy in vivo. However, the potency of
salivabactin and engineered probiotic in preventing or treating GBS infections remain unknown. The primary
objective of this proposal to evaluate the translational potential of two novel strategies, salivabactin and
engineered probiotic, to treat or prevent GBS infections in preclinical mouse models of infection simulating
various human disease manifestations. We will test our central hypothesis that salivabactin and salivabactin-
hyperproducing engineered probiotic are efficacious in controlling GBS infections in two specific aims. The
completion of this study will fully assess the translational potential of two novel therapeutic and prophylactic
strategies to treat streptococcal infections and identify new antibiotic- and probiotic-based strategies to combat
GBS infections.

Public health relevance
Group B streptococcus (GBS) is a major human pathogen and causes significant human morbidity and mortality worldwide. The proposed studies are relevant to the NIH mission as it involves identification and characterization of potentially novel therapeutic strategies for disease prevention and protect public health from GBS diseases.